Data Management and Distribution Core

Project Summary/Abstract, Data Management and Distribution Core (Core B)
The proposed program project aims to close research gaps in antiretroviral treatment for pregnant women and
infants living with HIV with four inter-related projects that will require data management and data sharing. The
Data Management and Distribution Core will build on its long experience managing clinical and laboratory data
at the Botswana-Harvard AIDS Institute Partnership to ensure successful support for all data aspects of this
program. Three projects (Projects 1, 3, and 4) will require database creation, maintenance, and support for data
collection and management. The Tsepamo Plus birth outcomes surveillance study (Project 1) will provide data
for the Methodology Project (Project 2) and for Point-of-Care HIV Testing and Infant Treatment (Project 3).
Project 3 will provide data for the Immune Control Study (Project 4). Projects 3 and 4 require systems for
receiving and storing laboratory data from the Botswana-Harvard HIV Reference Laboratory. The Data Core will
oversee an active and efficient system of cross-talk between projects to facilitate achievement of the P01
program goals internally. In addition, the Data Core will be responsible for routine and external data distribution,
and for data dissemination.